Evolved Heterogeneity Contributes to Chronic Fungal Lung Infections

Project Summary
During chronic fungal infections, heterogeneous subpopulations can arise. While these diversified
populations can pose significant challenges for treatment, they also provide an opportunity to identify pathways
under selection in vivo. This proposal focuses on the study of unique longitudinally-collected sets of Candida
(Clavispora) lusitaniae isolates from three individuals with cystic fibrosis (CF). In each case, the C. lusitaniae
infections replaced prior chronic bacterial infections, were associated with high levels of airway inflammation,
and were resistant to treatment. C. lusitaniae is an emerging agent of candidiasis known to develop resistance
to antifungal drugs and is a close relative of Candida auris, a multidrug resistant pathogen that has repeatedly
caused hospital associated outbreaks with high mortality. Through the genomic and phenotypic analysis of
variable traits in these chronic infection populations, via a productive collaboration between the Hogan and
Stajich Labs, we found striking heterogeneity in two genes: MRR1, which encodes a transcription factor known
for its ability to confer resistance to azoles, bacterial toxins, and host antimicrobial peptides, and MRS4, a
mitochondrial iron transporter that affects metabolism and metal uptake. We propose that these genes strongly
impact host interactions and fungal physiology in vivo. Our studies revealed that Mrr1 controls a large regulon of
resistance, metabolic and metal acquisition genes, and we discovered the first endogenous inducer of Mrr1,
methylglyoxal (MG), which spontaneously forms from intermediates in glycolysis. Further, we found that repeated
loss-of-function mutations in a second gene, MRS4, biases cells towards a glycolytic metabolism, increased MG
production, and increased Mrr1 signaling. We propose that these changes promote survival in an inflammatory
environment. Specifically, we propose to test the hypotheses that (Aim 1) endogenous MG directly stimulates
inducible Mrr1 variants, (Aim 2) that MRS4 loss-of-function mutations induce MG Mrr1 signaling through
increased glycolysis, and (Aim 3) that increased glycolysis decreases ROS accumulation in co-culture with
activated neutrophils. As we show in published and preliminary data, the pathways and mechanisms studied
here are conserved broadly across diverse Candida pathogens including C. auris. Through this work, we aim to
further develop our understanding of C. auris, and ways in which C. lusitaniae can be used as a highly tractable,
parallel system with an expanded tool kit including genetic, genomic, transcriptomic, and metabolomic resources. We
propose that the studies will reveal new broadly relevant mechanisms by which fungi adapt to the host environment
which can inform new treatment strategies.

Public health relevance
Project Narrative Candida lusitaniae is an opportunistic fungal pathogen known for its development of antibiotic resistance, that is a close relative to the multi-drug resistant pathogen Candida auris that is associated with hospital outbreaks. We study two types of mutations that arose repeatedly in C. lusitaniae infections and revealed new biology about pathways relevant for host interactions in diverse Candida species including C. auris.